Extracellular RNA Expression Biomarkers in Osteoarthritis Disease and Progression

PROJECT SUMMARY
Osteoarthritis (OA) is a progressive and degenerative joint disease with an increasing prevalence in the aging
population for which existing treatments targeting the primary symptom of pain are only minimally successful.
The manifestation of OA is heterogeneous with symptomology differing across individuals. This disease
heterogeneity has made identification of reliable and consistent molecular biomarkers elusive. This has in part
hindered the progress toward development of specific therapeutic treatments. Therefore, the identification of
specific biomarkers of OA clinical phenotypes and longitudinal changes over disease progression is required.
To begin addressing this issue, here we propose an initiative for the discovery of plasma extracellular RNA
(exRNA) expression signatures genomic signatures of OA among diverse clinical and progressive phenotypes.
exRNA has been demonstrated in a variety of complex diseases to have prognostic and biological value. The
experiments will utilize the Osteoarthritis Initiative (OAI) which is a prospective, longitudinal multicenter cohort
study of nearly 5000 subjects diagnosed with radiographic knee OA or at risk for the disease. We will first cluster
the entire OAI cohort into distinct clinical phenotypes based on biochemical assays, imaging data, and clinical
symptom questionnaires and identify exRNA signatures associated with those phenotypes using high throughput
RNA sequencing (SA1). Furthermore, we will identify individuals with progressive OA defined as progression by
radiograph changes over time as well as increasing pain over time. We will then generate longitudinal time-
course profiles of exRNA expression to deduce biological mechanisms of that progression (SA2).
By generating specific phenotype definitions, this study has increased power to identify molecular signatures
of these OA groups. This will be an important step toward harnessing the value of functional genomics as a
biomarker in the precision medicine of OA.

Public health relevance
PROJECT NARRATIVE Osteoarthritis (OA) is a common disease causing degeneration of the joints. It is complex with patients presenting with variable clinical indications. However, treatment strategies are limited to helping of only some symptoms such as pain, but not changing the course of the underlying disease. We propose an analysis extracellular RNA signatures that contribute to OA clinical subtypes and progression pattern unique to an individual. Using clinical phenotype clustering and plasma extracellular RNA expression signatures, our study may suggest novel molecular contributors to the disease and options for targeted therapeutics. Such functional biomarker identification can then be widely applied across OA phenotypes and populations to bring precision diagnosis and potential therapies to a broad section of those suffering from this disease.